A molecular dissection of BK channelopathy in neurological disorders

Project Summary
The KCNMA1-encoded BK Slo1 potassium channel plays a pivotal role in regulating neural activity and
neurotransmitter release. KCNMA1 variants, or channelopathies, have been increasingly identified in patients
with neurological disorders, representing a spectrum of clinical manifestations, ranging from epilepsy,
neurodevelopmental anomalies to movement disorders. Given this heterogeneity, precision medicine emerges
as a vital need for tailored diagnosis and treatment. To meet this challenge, our multidisciplinary team
hypothesizes that different KCNMA1 variants influence distinct molecular gating mechanisms, leading to
differential alterations of neuronal activities and varied clinical presentations. To test this hypothesis and to lay a
solid foundation for future investigation of more KCNMA1 channelopathies, we aim to unravel the genotype-
phenotype connections of three gain-of-function (GOF) KCNMA1 variants, D434G, A532V and N536H. Our
previous publications and preliminary studies show that these GOF variants alter distinct BK channel gating
mechanisms at the molecular level, and the patients show different clinical manifestations. In this proposal, we
will closely compare the molecular gating mechanisms (Aim 1), neuronal activities and knock-in mouse behaviors
(Aim 2) of these three GOF variants. In addition, we will strategically design and administer variant-specific
modulators to either mimic or mitigate KCNMA1 channelopathies to further test the variant-specific alterations of
neurological phenotypes. The variant-specific inhibitors may lead to the development of drugs with more
specificity and thus with minimal effect on people with normal BK channels. Through molecular analysis, mouse
model development, and innovative drug design, this research aspires to revolutionize our understanding of
KCNMA1 channelopathies and accelerate the advancement of precision medicine solutions.

Public health relevance
Project Narrative Mutations in the KCNMA1-encoded BK Slo1 potassium channel are linked to epilepsy, neurodevelopmental anomalies, and movement disorders. The present research aims to determine if the symptoms of the patients with the BK channel mutations are due to specific changes in BK channel function and to discover novel BK inhibitors that mitigate these mutational effects. Success will enhance our understanding of emerging neurological disorders associated with BK channel mutations and lay the basis for precision medicine solutions.